Discipline D-Special Projects; Track 2-NFSDX Integration or QRAPP Adoption

Project Summary Laboratory Flexible Funding Model (LFFM) (U19) Clinical Trials Not Allowed PAR-20-105 Florida Department of Agriculture and Consumer Services (FDACS) Division of Agricultural Environmental Services (AES) Proposal to FDA for Participation in the Laboratory Flexible Funding Model (LFFM) (U19) Clinical Trials Not Allowed PAR-20-105 Project Date: September 01, 2020 – August 31, 2025 The Florida Department of Agriculture and Consumer Services (FDACS) is requesting funding to enhance the capacity and capabilities of Florida's Animal Food testing laboratory in support of an integrated food safety system through participation in the Laboratory Flexible Funding Model (LFFM) (U19) Clinical Trials Not Allowed PAR-20- 105 for the discipline and analytical track listed below. Refer to the Overall and Individual Analytical Track Research Strategies for details. Discipline Analytical Tracks D: Special Projects Track 2: NFSDX Integration or ORAPP Adoption